Development of anti-LTBP4 as a biologic to treat Neuromuscular Diseases

PROJECT SUMMARY
Neuromuscular disorders are often heritable and typically result in progressive loss of strength and inability to
stand, walk, and breathe. Duchenne Muscular Dystrophy (DMD) is a inherited neuromuscular disorder caused
by the loss of dystrophin protein, which renders the muscle membrane highly susceptible to injury. Currently,
there are limited therapies available to correct the neuromuscular defects in DMD or delay disease
progression, although a number of treatments have been recently approved or are in clinical trials. Despite this
success, these treatments are only available to small percentage of patients and have limited efficacy. Latent
TGF-β Binding Protein 4 (LTBP4) was discovered as a genetic modifier of muscular dystrophy using an
unbiased genomewide screen. It was subsequently shown to have a similar genetic modifying signal in human
DMD patients. LTBP4 protein localizes to the myofiber exterior where it binds and sequesters all three forms
of TGF-β, regulating latent TGF-β release and activation and its subsequent cascade of pathological
downstream signaling. Excess TGF-β activation is a pathological finding in many forms of neuromuscular
disease, especially DMD, the limb girdle muscular dystrophies and the congenital muscular dystrophies. In the
muscular dystrophies, excess or hyper-activated TGF-β is linked to fibrotic infiltration of muscle and impaired
muscle regeneration. The genetic data was used to identify the hinge region of LTBP4 as critical to latent
TGF-β release and activation. LTBP4's hinge region can be proteolytically cleaved and this cleavage
promotes release of latent TGF-β, which is then fully activated by additional steps. The genetically protective
form of LTBP4 in mice is less susceptible to protease cleavage, correlating with a decrease of the normally
hyperactive TGF-β state in muscular dystrophy, and this correlates with delayed dystrophy progression. In
humans, the protective effect of LTBP4 correlated with longer ambulation in three independent DMD cohorts.
We devised an antibody strategy to stabilizes the LTBP4 hinge and limit latent TGF-β release. Proof of
concept data in the mdx mouse model of DMD demonstrates that an anti-LTBP4 antibody directed at the hinge
region can be used to mitigate disease progression. Anti-LTBP4 hinge region antibodies protected against
LTBP4 cleavage, reduced fibrosis formation, and enhanced recovery after muscle injury. This proposal outlines
the developmental plan of a lead LTBP4 biologic for the treatment of neuromuscular disorders split into two
phases. The first aim of phase 1 is designed to optimize the lead LTBP4 biologic and evaluate short-term in
vivo efficacy of the optimized leads. The second aim of phase 1 is to validate pharmacodynamic biomarker
assays. Aim 1 of the second phase will focus on pre-clinical studies and initiation of manufacturing, while aim
2 will progress the clinical candidate into BioPharm Early Development and IND filing.

Public health relevance
PROJECT NARRATIVE Neuromuscular disorders, including muscular dystrophy, are progressive muscle wasting disorders in which muscle is often replaced by fibrosis leading to reduced muscle function. We identified LTBP4 as a modifier of muscle disease and showed the protective forms of LTBP4 reduce fibrosis formation and delay disease progression in mice and humans with Duchenne muscular dystrophy. We are developing an anti-LTBP4 antibody as a biologic for the treatment of neuromuscular diseases.